T cell migration and cardiovascular toxicity in immunotherapy

T cell migration and cardiovascular toxicity in immunotherapy.
Adoptive T-cell transfer therapy has emerged as a promising therapeutic option with complete and durable
responses in several disease conditions such as viral infection, autoimmune disease, atherosclerosis, and
cancer. However, severe immune-mediated cardiovascular toxicities caused by cytokine release syndrome
(CRS) are observed in most patients, and these adverse reactions remain a significant obstacle in developing
effective and safe therapies. In studies conducted in the previous cycle of this grant, we showed that in vitro
activated T cells are immediately sequestered at the perivascular space of non-specific tissue sites after the
intravascular infusion. This non-specific accumulation is mediated by aberrant LFA-1 activation and may be
closely associated with impaired T cell functions and increased risk of severe CRS and cardiovascular toxicity.
In this study, we will build on these data and identify key mediators that can control the tissue-specific migration
of adoptively transferred T cells and harness these mechanisms to increase the efficacy of T cell immunotherapy
while reducing the risks associated with cardiovascular toxicity. To this end, we used (1) in vivo intravital multi-
photon microscopy to determine the fate of the adoptively transferred therapeutic T cells after infusion and
performed (2) an in vivo CRISPR–Cas9 knockout screen and (3) a high-throughput pharmacologic screening to
discover key T cell-intrinsic mechanisms that regulate therapeutic CD8 T cell migration to targeted tissue sites.
We will, (Aim 1) determine how clinically manufactured T cells interact with the endothelium in non-specific
tissues after infusion and impact vascular barrier functions, (Aim 2) determine the molecular mechanisms that
can minimize non-specific sequestration but improve specific T cell migration toward the target tissue site, and
(Aim 3) determine whether the newly discovered T cell homing mechanisms (Aim 1 and Aim 2) are associated
with therapeutic outcomes and the cardiovascular risk in patients. These studies will combine differential
perturbations of novel mechanisms that regulate activated T cell migration in in vivo mouse models, state-of-the-
art intravital multiphoton imaging, high-resolution pathway screenings, and assay analyses defining vascular
inflammatory responses.

Public health relevance
CAR-T cell immunotherapy has emerged as a promising therapeutic option with complete and durable responses in several cancer types. However, CAR-T cell therapies have largely failed in patients with solid tumors. We will investigate the molecular and cellular mechanisms that regulate CAR-T cell migration to target solid tumors. The effectiveness of clinical approaches using T cells will be enhanced by our discovery of important mediators that can improve the tissue-specific migration of adoptively transferred therapeutic T cells while minimizing sequestration at nonspecific tissue sites.